SERVICE RADIATION THERAPY

The purpose of this project is to provide expert radiotherapy, consultation, and treatment for patients of the Clinical Cancer Center including patients admitted to services other than the ROB. Support is given to the Medicine Branch, Surgery Branch, Pediatric Branch, NCI/Navy Medical Oncology Branch, Neurosurgical Service, Endocrine Service, and others.